MECHANISMS UNDERLYING INSECT STING SENSITIVITY

Hymenoptera sting sensitive persons who have received venom immunotherapy received deliberate insect sting challenges to assess the efficacy of therapy. In selected pts mast cell histamine release and histamine turnover studies are performed in parallel, to determine if persons who are immunotherapy failures have identifiable abnormalities in mediatcr release or metabolism.